COPPER METABOLISM IN HUMAN HEPATOCYTE DERIVED CELL LINE

The mammalian liver is the central organ for the maintenance of copper homeostasis. This balance is achieved through the interplay of uptake of copper by the hepatocytes, incorporation of the metal into constitutive and export proteins, storage in certain organelles and excretion of the excess copper via the bile. In order to better identify and characterize these functions, we plan to use a human hepatoblastoma derived cell line, HepG2. This in vitro system should help identify the intracellular storage proteins as well as the site where copper is incorporated into the export glycoprotein, ceruloplasmin. The effects of copper toxicity on cellular structure and function caused by increasing copper concentrations will be studied. The isolation and characterization of mutants tolerant to excessive amounts of copper will be attempted in order to elucidate the nature of alterations of copper homeostasis. These studies should contribute to a better understanding of the mechanisms that regulate or disturb copper balance in human subjects who suffer from one or another form of hepatic copper toxicosis, namely Wilson's disease, Indian childhood cirrhosis, idiopathic copper toxicosis and primary biliary cirrhosis. Detailed knowledge of the effects of chelating agents on copper uptake, storage and efflux at the cellular level should lead to the design of improved therapeutic regimens for patients and animals suffering from hepatic copper overload.